Development of a multi-RNA signature in blood towards a rapid diagnostic test to robustly distinguish patients with acute myocardial infarction

ABSTRACT
Chest pain, the main symptom of acute myocardial infarction (AMI), accounts for ~5% of all emergency
department (ED) visits. In the absence of ECG abnormalities, diagnostic gold standard for AMI relies on serial
troponin (cTn) measurements which are inconclusive in 20-40% of patients, requiring additional testing and
prolonged observation in the ED. A missed diagnosis of AMI without proper treatment is life threatening and
thus rule-out diagnosis requires very high sensitivity. Hence, a rapid point of care (POC) test utilized as an
adjunct to cTn with enhanced diagnostic performance would be revolutionary for risk stratification and timely and
safe triaging of patients with suspected MI in ED.
Inflammatix is a molecular diagnostics company focused on developing and bringing to market best in class,
immune response based, data-driven testing. We developed a point-of-care instrument, MyRNA™, capable of
quantitating up to 64 mRNAs in under 30 minutes (with <2 minutes operator time), directly from patients’ blood,
in a fully disposable cartridge. We specialize in use of state-of-art multi-cohort analysis and machine learning
(ML) to identify and validate robust biomarkers that generalize across real-world data heterogeneity, in diverse
clinical contexts. Previous work demonstrated the potential of blood gene expression as a biomarker for MI,
however a clinical test based on immune response in blood gene expression is yet to be developed. We applied
our analytical framework to 6 publicly available datasets and identified a multi-gene AMI signature in peripheral
blood that allows us to differentiate patients with AMI from clinically relevant controls with AUC ~ 0.95.
In this project, we propose to take the AMI signature from preliminary results through research and initial
development stages, up to formal clinical diagnostic development. We will generate a significant amount of
independent data, leverage Inflammatix ML capabilities to further refine the mRNA signature and deliver a robust
classifier ready for validation in prospective studies. In Specific Aim 1, we will generate, process, and analyze
RNA-seq data for 900 blood samples from retrospective cohorts closely representing the target test population.
In Specific Aim 2, we will first refine, optimize, and validate the mRNA signature; and then develop a prototype
ML classifier. Specifically, we will 1) integrate expression data from all cohorts while minimizing bias; 2) apply
Bayesian multi-cohort framework for final gene set selection with 300 new samples; 3) develop and evaluate
discriminatory performance of AMI classifier prototype; and 4) validate the AMI classifier prototype on 600
unseen samples. These steps will produce: i) a validated set of genes for AMI; ii) an integrated dataset; and iii)
a classifier prototype (AUC > 0.90), ready for clinical validation via prospective studies in Phase 2 research. This
test, when developed as a cartridge on Inflammatix’s POC instrument, MyRNA™, will facilitate clinician’s triaging
decisions of patients with suspected MI, improve patient outcomes, and reduce healthcare costs.

Public health relevance
NARRATIVE This project addresses the significant clinical need to develop a rapid, clinically useful point of care (POC) test with enhanced diagnostic precision for patients presenting with suspected myocardial infarction (MI). Harnessing meta-analysis and machine learning, and embracing heterogeneity found in multiple cohort and real-world applications, this project will discover and validate a discernable blood gene expression response to MI. Success would be revolutionary in risk stratification and safe triaging of patients with suspected MI, positively affecting patient management and outcomes, and optimizing healthcare spending and Emergency Room occupancy.